The role of PTEN in DNA metabolism and replication

RESEARCH SUMMARY
The goal of this project is to understand the role of PTEN in DNA metabolism and replication. Phosphatase and
tensin homolog deleted on chromosome ten (PTEN) is one of the most frequently lost or mutated tumor
suppressors in cancer, commonly lost in endometrial cancer, glioblastoma, breast cancer, and prostate cancer.
PTEN is a dual-specificity phosphatase whose main substrate is the lipid second messenger
phosphatidylinositol-3,4,5-trisphosphate (PIP3), and PTEN activity negatively regulates the phosphoinositide 3-
kinase (PI3K)/AKT growth signaling pathway. Work in our lab and others has shown that the deletion of both
alleles of PTEN causes increased growth rate and proliferation in a variety of normal tissues, including in primary
mouse embryonic fibroblasts (MEFs). Additionally, we have demonstrated a glutamine dependency, an
increased glutamine flux into de novo pyrimidine synthesis, and an increased sensitivity to pharmacologic
inhibition of de novo pyrimidine synthesis in primary Pten–/– MEFs. We propose that these results implicate the
nucleotide metabolism, the cell cycle, and DNA replication as potential avenues through which the loss of PTEN
could contribute to deregulated growth. We posit to explore these pathways using primary Ptenflox/flox MEFs as a
model system.
In Aim 1, we will investigate how the loss of PTEN expression sensitizes cells to inhibition of de novo pyrimidine
synthesis through altered cell cycle dynamics. To investigate the molecular basis of this sensitivity, we will
examine DNA damage and replication stress, cell death, and cell cycle checkpoint activation after pharmacologic
inhibition of de novo pyrimidine synthesis in primary Pten–/– MEFs. Given the potential use of leflunomide for
patients with PTEN-deficient tumors, a comprehensive understanding of the cellular consequences of
leflunomide treatment in the context of PTEN loss will enable more effective use.
In Aim 2, we will characterize the impact of PTEN loss on the duration of S phase and DNA replication efficiency.
To determine the length of S phase in primary Pten–/– MEFs, we will use two experimental methods that allow
for the determination of S phase length: dual-pulse DNA replication labeling with thymidine analogs and live cell
imaging in combination with fluorescent-labeled cell cycle-specific proteins. To investigate DNA replication
efficiency, we will perform fiber combing to directly visualize replicating DNA. Knowledge of the mechanism
behind altered replication dynamics in the context of PTEN loss would contribute to the basic understanding of
the mechanisms of evading growth regulation in cancer cells.

Public health relevance
Research Narrative PTEN is one of the most frequently lost or mutated tumor suppressors in cancer, commonly lost in endometrial cancer, glioblastoma, breast cancer, and prostate cancer; and work in our lab has implicated PTEN in cell signaling and DNA metabolism and replication. In this project, we will investigate how the loss of PTEN expression sensitizes cells to inhibition of DNA metabolism, and we will characterize the impact of PTEN loss on DNA replication dynamics. This project would further the understanding of the mechanism of action in cancer of FDA-approved medications and further the understanding of the basic mechanisms of how tumor suppressors avoid growth suppression in cancer.